Personalized Networks and Sensor Technology Algorithms of Eating Disorder Symptoms Predicting Eating Disorder Outcomes

PROJECT SUMMARY/ABSTRACT Eating disorders (EDs) are severe mental illnesses with the highest mortality rate of any psychiatric disorder. The most widely used empirically supported treatment for EDs (cognitive behavior therapy) is only efficacious for ~50% of individuals. This low response rate is due to the fact that EDs are heterogeneous conditions with diverse symptom trajectories that are not adequately addressed in current “one-size-fits-all” psychotherapies. Until we can identify what maintains or exacerbates individual symptoms, clinicians will continue to have difficulty accurately predicting prognosis and will have no empirical guidance to develop targeted treatment plans to promote recovery. Our scientific premise, developed from our past work, is that the application of network theory will enable the identification of cognitive-behavioral symptom networks that maintain and “trigger” EDs both between and within individuals. Our study goals are to (1) identify individual ED “trigger” symptoms (cognitions, behaviors, affect, and physiology) and (2) correlate trigger symptoms with real-time physiological data to create an algorithm predicting onset of ED behaviors. These goals will ultimately identify symptoms that prevent full remission and lead to relapse. We will use a multiple units of analysis approach combined with novel, cutting-edge advances in network science. We will collect intensive real- time data on cognitions, behavior, affect, and physiology using mobile and sensor-technology from 120 individuals with a diagnosis of anorexia nervosa (AN), atypical AN, and bulimia nervosa across 30 days. At 1-month and 6-month follow ups we will assess ED outcomes (e.g., remission status, ED behaviors) to test if “trigger” symptoms predict ED outcomes. Network science and state-of-the-art machine learning techniques will allow us, for the first time, to discover whether certain trigger symptoms predict worse outcomes. Specific aims are to (1) develop personalized networks to identify which cognitive, behavioral, affective, and physiological symptoms maintain EDs and predict ED outcomes and (2) utilize sensor data to identify physiological patterns both within and across people that correlate with core maintaining symptoms and that predict ED behaviors. The proposed research uses highly innovative methods, combining intensive longitudinal data collection methods, all remote procedures, novel advances in network science and sensor-technology, and state-of-the-art machine learning techniques to answer previously unresolvable questions pinpointing which personalized symptoms trigger EDs. The proposed research has clinical impact. If we identify patterns that contribute to symptom network variation within individuals, these data will provide a model of personalized medicine for the entire field of psychiatry, as well as providing novel intervention targets to prevent and treat EDs.

Public health relevance
PROJECT NARRATIVE This project will identify the maintaining symptoms of eating disorders within individuals. The proposed research has significant public health relevance, as it will lead to personalized, novel, effective treatments that promote full remission and decrease the high societal burden associated with eating disorders. The proposed research is relevant to NIH’s precision medicine initiative, as it will identify within-person, maintenance symptoms of eating disorders, leading to personalized treatments delivered via mobile or sensor technology.